Conformational dynamics and allosteric regulation during stress-responsive metallocofactor assembly

There are no changes to the Project Summary of the parent proposal.

Public health relevance
There are no changes to the Project Narrative of the parent proposal.